NCE FOR COMMERCIALIZATION CENTER TASK ORDER FOR CANCER SCREENING RESEARCH NETWORK

NCE FOR COMMERCIALIZATION CENTER TASK ORDER FOR CANCER SCREENING RESEARCH NETWORK - CONSULTANT TO ESTABLISH ASSAY EVALUATION STRATEGY